Prevalence and correlates of adverse pregnancy outcomes following female genital fistula repair in Uganda: a mixed-methods study

ABSTRACT
Female genital fistula is a debilitating injury that affects 2 to 3 million women, mostly in sub-Saharan Africa.
Women with fistula have uncontrollable leakage of urine and/or feces (among other physical symptoms), are
heavily stigmatized, and experience high psychiatric morbidity. Preliminary evidence has identified risk of
adverse pregnancy outcomes following fistula repair. However, the evidence base is not well developed, and
robust estimation of stillbirth and other adverse pregnancy outcomes as well as characterization of factors
contributing to post-repair pregnancy outcome is necessary for informing successful interventions to improve
women's health following fistula repair.
In an effort to improve the physical and psychosocial quality of life for women affected by fistula, we propose to
address the critical gaps in knowledge on risk of adverse pregnancy outcomes following fistula repair through
an explanatory sequential mixed-methods project among 200 women who have undergone fistula repair in the
past 5 years at 4 fistula repair facilities in Uganda. We seek to quantitatively estimate the incidence of adverse
pregnancy outcomes following fistula repair (Aim 1); and understand post-repair pregnancy decision-making
and health care experiences of women previously repaired for genital fistula through in-depth interview with key
stakeholders (women and providers); Aim 2).
The research proposed herein will develop a robust estimate of stillbirth following fistula repair, and represents
a first step toward establishing our understanding of factors contributing to adverse pregnancy outcomes in
Uganda. It will directly support the development of a subsequent research proposal (R01) which will allow us to
estimate risk factors of adverse post-repair outcomes and translate our findings into counseling and clinical care
models for optimizing women's health and wellbeing in this population. Overall, our research program is expected
to result in higher physical and psychosocial quality of life in both the short and long term for the increasing
number of women undergoing surgical repair of female genital fistula, in Uganda and elsewhere.

Public health relevance
Narrative Nascent evidence suggests that adverse pregnancy rates are elevated among women affected by genital fistula following surgical repair; as fistula occurs in high fertility settings and many women desire more pregnancies following fistula repair, attention to understanding and preventing adverse post-repair pregnancy outcomes is critical. Through a sequential explanatory design, we seek to robustly estimate the incidence of stillbirth, spontaneous abortion, and preterm birth in post-repair pregnancies, and understand the individual, interpersonal and systems-based contributors to adverse outcomes. This study will identify salient targets for clinical and counselling interventions to improve women's health and quality of life following fistula repair.